J. NRSA Training Core

The fundamental goal of the Weill Cornell Clinical and Translational Science Center TL1 Training Core Program is to equip predoctoral and early postdoctoral trainees from multiple disciplines with the skills necessary to pursue transformative clinical and translational research before their career paths are established by offering distinct educational tracks culminating in advanced degrees that allow trainees to make an immediate impact in the clinic or in industry. The TL1 Training Program has trained highly successful predoctoral medical students, surgical residents and early graduate students, nurses and fellows recruited from all partner institutions. The TL1 trainees are fully integrated into CTSC activities and have access to all services provided by CTSC partners. Building on our successful training program developed over the last 14 years, we will introduce new courses, technologies, and workshops geared towards team-based research, creativity, leadership, innovation, entrepreneurship, informatics, and precision medicine. The TL1 program offers a panoply of didactic programs available to TL1 Scholars including an Advanced Certificate in Clinical/Translational (C/T) Investigation intended for trainees who are interested in learning the fundamentals of Clinical and Translational Research; a Master’s Program in Clinical and Translational Investigation, the foundation of which is a Mentored Research Capstone Project in C/T research that is conducted in a team environment; an - MD/MS, program, a Summer Fellowship in C/T research; and innovative seminars, workshops, and courses offered throughout the year. Other groundbreaking training includes mentored research and externships/mini-sabbaticals with biopharmaceutical companies that will enrich trainees’ exposure to various career options in clinical and translational research. The highly skilled TL1 faculty and mentors are expertly trained to offer support for trainees throughout the program in order to help them pursue successful translational research careers. The CTSC has also established multiple collaborative resources to recruit and retain scholars The enhanced TL1 will leverage the trainees to more rapidly advance in the field of Clinical and Translational Science. The planned duration of appointments is two years and, the projected number of trainees is 10 including 5 predoctoral, 5 postdoctoral trainees.